Tissue Perfusion Pressure for Improved Management of Circulatory Shock

Circulatory shock is one of the most common reasons for admission to an intensive care unit (ICU) and results
from inadequate blood pressure and blood flow to support organ function. Causes of circulatory shock include
heart failure, sepsis, and hemorrhage. Prompt treatment is required to restore adequate blood pressure to
prevent severe organ injury and death. Consensus guidelines for treatment of shock provide general targets for
mean arterial pressure (MAP) that can be used to adjust medications, but optimal individual pressure goals for
patients with various diseases and comorbidities remain uncertain. Prospective randomized clinical trials
looking at different patient populations have generally failed to show a mortality benefit for higher versus lower
MAP goals, and MAP alone has therefore proven an inadequate single measure of tissue perfusion. This
project seeks to develop a novel hemodynamic metric called tissue perfusion pressure (TPP) for use in
patients with circulatory shock. This metric defines the pressure drop across the systemic circulation as the
difference between MAP and the critical closing pressure (Pcrit), which is the arterial pressure when blood flow
stops and the circulation collapses. It has generally not been possible to measure Pcrit in patients with an
intact circulation, however, and this physiology has been largely ignored in clinical practice. The proposed
approach, developed using analyses from thousands of patients, now allows estimation of Pcrit from standard
blood pressure monitors in the ICU and enables continuous calculation of TPP to augment standard
hemodynamic measures. The fundamental hypothesis of this project is that TPP can provide individualized
blood pressure targets for critically-ill patients and can therefore guide titration of fluid and vasoactive
therapies. This hypothesis will be tested in three specific aims. Aim 1 will investigate the physiology of Pcrit and
TPP in preclinical animal models of circulatory shock and resuscitation using extensive physiologic
phenotyping. Measured data will be incorporated into new circuit models of organ perfusion during shock. Aim
2 will next analyze distinct shock cohorts using computational approaches applied to a large clinical database
of ICU patients, with the goal of identifying patterns in TPP response in various forms of shock and to standard
of care therapeutics. Aim 3 will then develop a computational pipeline to perform real-time analysis of TPP for
implementation in clinical decision support tools. Clinical feedback on the novel metrics will be obtained from
expert critical care clinicians. If successful, this project will advance TPP as a potential therapeutic target for
diagnosis and management of circulatory shock and set the foundation for design of future prospective clinical
trials.

Public health relevance
This project develops a new approach to monitoring blood pressure in patients with a life threatening condition known as circulatory shock, which can be caused by many causes including heart failure, overwhelming infection, or bleeding. The method uses computational techniques to provide an improved description of the actual perfusion pressure driving blood flow to vital organs during shock, and may therefore be used to guide clinical diagnosis and management of therapies aimed at treating shock. The project will combine studies from preclinical animal models and clinical patients to validate the new approach.